Notch signaling and germline-soma interactions in the Drosophila ovarian model

PROJECT SUMMARY
Cell-cell communications among different cell groups, especially between the germline and somatic cells, are
key to the development of a functional egg. At the center of germline-soma interactions in the Drosophila
model lies the Notch pathway, which plays critical roles in a series of major events during oogenesis.
Determining how Notch signaling regulates diverse cellular processes is fundamental to the understanding the
regulation of oogenesis. On the other hand, the ovarian model offers an excellent platform to uncover novel
regulatory mechanisms of this notoriously important pathway, with roles crucial in development, tissue
homeostasis and pathogenesis of a multitude of human diseases. Despite many years of studies, there are still
a significant number of unknowns in the field. For example, how Notch regulates growth in different
developmental or pathological contexts, how the cell cycle machinery feeds back to modulate the Notch
pathway and how environmental stresses impact the signaling output during development and tissue
homeostasis. This proposal aims to address these questions using the genetically tractable Drosophila
ovarian model system.
The proposed studies are based on a series of previous findings and preliminary results. We have
shown that Notch signaling induces cell differentiation by switching the follicle cells from the mitotic cycle to an
endoreplication cycle, thus restricting cell proliferation. Interestingly, when combined with a loss of cell polarity
gene lgl, we found that Notch promotes tissue growth in the follicle cell epithelium. We also found that String
(Stg), a Cdc25 homolog, regulates the nuclear access of an active form of Notch, the Notch intracellular
domain (NICD). Furthermore, we found that hyperactivation of Notch in follicle cells causes cell death and
degeneration of germline cells through phagocytosis. These findings provide us the opportunity to further
explore how germline and somatic development are coordinated during normal development and under
environmental stresses, and to understand how Notch signaling regulates growth and survival in various
biological and pathological conditions. The following three specific aims will be addressed using the ovarian
model.1. To determine how Notch regulates tissue growth in different genetic backgrounds. 2. To determine
how Cdc25/String regulates NICD nuclear access to impact Notch signaling. And 3. To determine how
upregulated Notch activity in follicle cells induces germline cell death. Successful completion of these aims will
lead to improved understanding of the diverse effects and regulatory mechanisms of Notch signaling during
development and tissue homeostasis. The findings from the proposed studies will help designing new
therapeutic strategies for diseases related to aberrant Notch signaling.

Public health relevance
PROJECT NARRATIVE The Notch signaling pathway has been implicated in a wide range of biological and pathological processes. Using the Drosophila ovarian model, the proposed studies will lead to improved understanding of the diverse effects and regulatory mechanisms of Notch signaling during development and tissue homeostasis. The findings from the proposed studies will help designing new therapeutic strategies for diseases related to aberrant Notch signaling.